AI-enabled occult bleeding detection and monitoring

Project Summary/Abstract
Internal hemorrhage is the second leading cause of death following trauma, with missed abdominal
bleeding contributing to significant late-stage mortality and morbidity. Current diagnostic approaches,
such as Focused Assessment with Sonography for Trauma (FAST) and computed tomography (CT),
require trained personnel, are not portable, and provide only intermittent assessments. These limitations
are particularly acute in field and pre-hospital environments, where rapid diagnosis and triage are critical,
but expertise and imaging capabilities are limited or unavailable.
This STTR Phase I project proposes to develop and evaluate a novel point-of-care diagnostic
device based on electrical impedance tomography (EIT) that enables automated detection and
monitoring of internal bleeding. The proposed system uses a compact array of electrodes and machine
learning-enhanced imaging algorithms to provide real-time information on bleeding volume and rate. It is
designed for immediate use by non-expert personnel and aims to support timely triage and transport
decisions in both civilian and military trauma settings.
Specific Aim 1: Optimize machine learning algorithms for accurate bleeding detection using reduced-
sensor EIT arrays. We will train deep neural networks to mitigate movement and breathing artifacts and
validate performance using a cadaver model capable of simulating realistic bleeding and respiratory
motion.
Specific Aim 2: Develop and test a candidate housing for the prototype device in volunteer firefighter
subjects. We will evaluate sensor application, ease of use, and device performance in fluid monitoring
scenarios, alongside feedback from users on form factor and usability.
This project leverages the academic team’s extensive background in electrical imaging and the small
business partner’s expertise in medical device development. Success in Phase I will establish the
technical foundation and user requirements needed to advance to a Phase II effort focused on
ruggedization, expanded clinical testing, and regulatory preparation.
The long-term vision is to produce a lightweight, self-interpreting hemorrhage detection system
that can be integrated into trauma workflows across EMS, battlefield, and rural settings—ultimately
improving survival outcomes through earlier, more accurate identification of internal bleeding.

Public health relevance
PROJECT NARRATIVE Concealed hemorrhage is a frequent cause of death after blunt trauma. We propose an efficient point- of-care electrical imaging unit, enabling first responders to quickly assess bleeding and direct patients to appropriate care. The device has potential applications in civilian or military use.